CHARACTERIZATION AND DIAGNOSIS OF INFECTIOUS AGENTS FROM CHRONIC DISEASES

In vivo and in vitro translation studies have shown that genomic RNA of simian hemorrhagic fever (SHF) virus codes for both structural and nonstructural polypeptides. Virions were shown to contain 3 structural polypeptides of approximately 50K, 18K and 12K, the largest of which is a glycoprotein. SHF virus RNA also was found to have a type 1 cap structure. In these characteristics, SHF virus has the replication strategy, number of type of polypeptides and cap structure of Flaviviridae, a recently formed virus family.